Bridging the evidence-to-practice gap: Evaluating practice facilitation as a strategy to accelerate translation of a systems-level adherence intervention into safety net practices

Project Summary: Despite increasing awareness and treatment of hypertension (HTN) across all racial/ethnic
groups, Latinos have the lowest blood pressure (BP) control rates in the US (Latino adults: 34% vs. 43% and
53% in non-Hispanic black and white adults). These statistics may be explained by the disproportionately
poorer adherence to antihypertensive medications among Latinos compared to blacks and whites. Systems-
level interventions conducted in primary care settings have improved medication adherence in minority
populations. Our Ayudando a Latinos Hipertensos Para Mejorar Adherencia a sus Medicamentos (ALMA) trial,
which informs this proposal significantly improved both BP control (51 vs. 29%, p=.04) and medication
adherence (78 vs. 72%, p=.02) compared to enhanced usual care in a sample of 119 Latino patients followed
in a safety-net practice. Despite their efficacy, evidence-based interventions like ALMA often take up to 17
years to be translated into clinical practice. Implementation strategies are sorely needed to accelerate the
translation of evidence-based interventions into routine “real world” safety-net practices, in order to reduce
disparities in BP control in vulnerable populations. Practice facilitation (PF) is one method to accelerate the
implementation of evidence-based interventions into healthcare settings. Through PF, a facilitator works with
healthcare teams to develop the skills to adapt and implement evidence-based system changes and promotes
a tailored approach to integrating those changes into the clinic workflow. Although evidence supports the effect
of PF for preventive screenings (e.g., breast examination), its impact on implementing evidence-based
systems approaches to support HTN management in safety-net practices remains largely untested. This
proposal provides an opportunity to fill this evidence-to-practice gap by evaluating the effectiveness of PF as a
practical and replicable strategy for implementing ALMA in a network of 12 safety-net Family Health Centers
(FHCs) in New York City. Using a mixed-methods design, we will conduct this study in two phases: (1) A pre-
implementation phase where we will refine the PF strategy, informed by our prior work, based on the
Consolidated Framework for Implementation Research to facilitate the implementation of ALMA at the FHCs.
(2) An implementation phase, during which we will evaluate, in a pragmatic cluster-randomized controlled trial,
the effect of the PF strategy compared to a self-directed condition (i.e., receipt of information for implementing
ALMA but no facilitation) on implementation fidelity (primary outcome) of ALMA and on clinical outcomes
(secondary outcome) at 12 months among a sample of 650 Latinos with uncontrolled HTN cared for at the
FHCs. Implementation fidelity will be assessed using a mixed methods approach based on the five core
dimensions of implementation fidelity, as defined by Proctor’s Implementation Outcomes Framework. Clinical
outcome measures include BP control (defined as <140/90 mmHg) and medication adherence (assessed
using the proportion of days covered via pharmacy records).

Public health relevance
Project Narrative: Latinos with hypertension (HTN) are twice as likely to have uncontrolled blood pressure (BP) compared to whites, despite similar prevalence of HTN in both groups; poor adherence to prescribed antihypertensive medications among Latinos may explain this racial gap. Despite a wealth of research dedicated to developing interventions to improve medication adherence in patients with uncontrolled HTN, the translation of these interventions into routine practice within “real world” safety-net primary care settings has been inadequate and slow. Identifying practical and replicable strategies that are effective for facilitating the translation of efficacious interventions into routine practice in safety-net settings are sorely needed to improve the poor rates of medication adherence and BP control among Latinos—thereby supporting the goals of the health care reform law to ensure the delivery of efficient and high quality health care services through coordinated, comprehensive and patient-centered care.